Core I: Immunology, Retrovirology and Cure

Project Summary/Abstract
The newly merged Immunology, Retrovirology and Cure (IRC) Core will provide technological expertise,
practical support, consulting, and mentorship in HIV laboratory sciences. Based on our and NIH’s evaluation of
recent progress and remaining research gaps, we aim to especially support three priority areas: 1) HIV latency
and cure, 2) HIV vaccine design for prevention and cure, and 3) the processes underlying chronic inflammation
and comorbidities in people living with HIV (PLH). We also plan to target our support to 1) early-stage
investigators, e.g., by convening a Junior Investigator Group (JIG) monthly; 2) underrepresented minority
(URM) investigators, leveraging activities towards increasing URM participation at our institutions and in
collaboration with our Office for Community Engagement (OCE); and 3) basic scientists new to HIV/AIDS,
ensuring that information about HIV-related NIH concepts, RFAs, and key conferences and workshops are
disseminated to basic scientists in Seattle who have primarily conducted research in other fields. We will also
provide specific suggestions for potential collaborations with our IRC Core faculty, members, and users.
The extreme diversity of HIV necessitates continual reevaluation of how innate and adaptive immune
responses change the composition of HIV quasi-species, and, conversely, of how the biology of HIV and
therapeutic interventions (for example the induced reactivation of latent proviruses) influence antiviral
immunity. To emphasize this intricate link between virus biology and antiviral immunity, we are proposing to
unite virus-focused and immunity-focused laboratory sciences into a single core, co-led by a virologist (Dr.
Keith Jerome) and an immunologist (Dr. Florian Hladik). A combined core, supported by a single, highly
experienced, and dedicated core administrator (Tom Andrus), will provide a streamlined user experience,
enabling us to optimally consult investigators on selecting and implementing the most appropriate techniques
for their research questions. Merging of scientific expertise and resources into one Core is also responsive to
CFAR member surveys by simplifying access to the large array of expertise, instruments, and assays we offer.
Our Specific Aims are to : 1) Offer scientific guidance and consultation to investigators, with special focus on
those at an early career stage (ESI), from underrepresented or disadvantaged groups, or new to HIV science;
2) Provide access to and consult on laboratory assays and instruments; 3) Enable studies in animal and ex
vivo tissue models of HIV infection and treatment; 4) Encourage the use of specimen and data repositories, in
a joint effort with the Clinical and Comorbidity Research (CCR) Core. We will assess our impact with these
aims by rigorously collecting metrics of our success, which will include demographic data to verify that we are
increasing user diversity over time. Most importantly, over the 5-year period of this award, we strive to increase
the scientific impact of the IRC Core, as measured by research reports published with our support and
HIV/AIDS-focused grants received by our users.